Interactions between Pseudomonas aeruginosa and Streptococcus salivarius and effects on the host immune response

PROJECT SUMMARY
Pseudomonas aeruginosa is a multi-drug resistant pathogen which causes chronic lung infections and is a
leading cause of mortality in cystic fibrosis (CF) patients. P. aeruginosa produces a biofilm matrix which protects
the bacterium from antimicrobials and aids in host immune evasion. The main component of this biofilm matrix
are three exopolysaccharides- Pel, Psl, and alginate. Additionally, P. aeruginosa contributes to inflammation and
lung damage by activating the pro-inflammatory NF-κB pathway in host cells, leading to the production of
inflammatory cytokines and recruitment of inflammatory immune cells to the lungs, causing subsequent tissue
damage. NF-κB activation is naturally elevated in the lungs of CF patients, which is further exacerbated by P.
aeruginosa infection. Although P. aeruginosa is generally studied as an isolated infection, other species colonize
the lungs of CF patients and could potentially modulate P. aeruginosa virulence. Colonization of oral streptococci
in the lungs has recently been associated with CF lung stability. Of these oral streptococci, Streptococcus
salivarius, was found to be the most prevalent streptococcal species in the lungs of CF patients. S. salivarius
has been shown to inhibit growth of multiple respiratory pathogens, as well as inhibit activation of the NF-κB
pathway in human bronchial epithelial cells. Although S. salivarius has been correlated with stable lung function
in CF patients, no studies have examined interactions between S. salivarius and P. aeruginosa and their impact
on the host response. To characterize the interactions between the two species, we first measured changes in
biofilm formation of the two species when co-cultured. Our preliminary results demonstrated that S. salivarius
biofilm formation is significantly increased in the presence of the exopolysaccharide Psl, which is produced by
the non-mucoid P. aeruginosa strain PAO1. Additionally, the S. salivarius maltose-binding protein MalE was
overexpressed in the presence of P. aeruginosa. Aim 1 will test the hypothesis that MalE interacts with Psl to
promote biofilm formation of S. salivarius. Whole-cell ELISA and isothermal titration calorimetry will be used to
characterize the binding affinity of the two targets. Our preliminary data also demonstrated that Drosophila
melanogaster were protected from P. aeruginosa-mediated killing in the presence of S. salivarius, highlighting
the need to further examine the impact of S. salivarius on P. aeruginosa pathogenesis. Aim 2 will test the
hypothesis that the presence of S. salivarius in the CF lung improves lung function by downregulating pro-
inflammatory cytokines downstream of NF-κB produced in response to P. aeruginosa infection. We will develop
a CF rat model of co-infection in which we measure specific pro-inflammatory cytokines, neutrophil recruitment,
and lung histopathology during P. aeruginosa infection in the presence or absence of S. salivarius. Data
generated from this proposal will promote our understanding of how S. salivarius incorporates into the P.
aeruginosa biofilm and modulates the host response to a P. aeruginosa infection.

Public health relevance
PROJECT NARRATIVE Pseudomonas aeruginosa contributes to lung deterioration in cystic fibrosis patients in part by exacerbating inflammation and causing subsequent tissue damage in the lungs. The proposed research will investigate interactions between P. aeruginosa and Streptococcus salivarius, a commensal bacterium associated with stable lung function in CF patients, and how these interactions impact the host inflammatory response. Findings from this work will uncover how commensal-pathogen interplay in polymicrobial infections can impact disease outcomes.